Biomarkers of Cerebral Cavernous Angioma with Symptomatic Hemorrhage (CASH) - Supplemental

SUMMARY
Cerebral cavernous angioma (CA) is a capillary microangiopathy affecting more than a million Americans,
predisposing them to a premature risk of brain hemorrhage. Fewer than 200,000 cases who have suffered a
recent symptomatic hemorrhage (CASH) are most likely to re-bleed again with serious clinical sequelae, and are
the primary focus of trial readiness and therapeutic development. Candidate biomarkers are emerging from
ongoing mechanistic and differential transcriptome studies, which enhance the diagnosis and prediction of
CASH, influence clinical decisions, and help stratify high-risk cases in clinical trials. An ongoing project
(R01NS114552) has assembled leading clinical CA researchers to deploy advanced computational biology
approaches, including supervised machine learning (ML), to discover and validate novel candidate biomarkers.
It aims to determine the best clustering and weighing of combined biomarker contributions for optimal diagnostic
and predictive accuracy. Initially aimed at combining levels of candidate proteins and microRNAs, recent
discoveries have compelled the inclusion of circulating metabolites with mechanistic links, which demonstrate
strong diagnostic and prognostic associations in discovery cohorts. The best weighted combination of plasma
molecules will be tested in a large validation cohort already recruited, to assess their relevance in sex, age,
relevant clinical subgroups and multiple recruitment sites. The project tests a novel integrational approach of
biomarker development in a mechanistically defined cerebrovascular disease with a relevant context of use.
While applicable to other neurological diseases, the implementation of our data for ML analyses, and its use and
usability by other investigators, are limited by inconsistent structure of shared data in current repositories.
Furthermore, there is a lack of harmonization of data elements or intuitive connectivity of multiomic data elements
from the same patients. This problem is amplified with the addition of metabolites to our multiomic biomarker
candidates. In response to NOSI NOT-OD-23-082, we have assembled a team with expertise in computational
biology, clinical biomarker research, data science and statistics, who will work on solutions to address these
issues. First, we will share each type of raw data in structured repositories that match each type of assay and
data type. We also designed a database under best practices for data structure, standardization, and naming
conventions that we will share through Dryad, which will include data that is ready for ML and other AI and Deep
learning implementations. We further propose creating a GitHub repository that will include a detailed description
of the data in Dryad and the codes used for the ML implementation in our study. We will connect the different
submissions to the repositories to facilitate the use of more than one data type from the same subjects. Lastly,
in addition to publishing the primary results of ML multiomic data analyses from this project, we propose to
publish a methods paper on connected shared data structure for readiness in future ML, artificial intelligence and
deep learning analyses by other investigators.

Public health relevance
PROJECT NARRATIVE Machine learning (ML) analyses have been used to derive weighted combinations of levels of plasma proteins, microRNAs and most recently metabolites, for accurate diagnosis and prediction of hemorrhage in cavernous angioma, a disease affecting more than a million Americans. Current repositories for sharing such data include inconsistent and disconnected elements, limiting its use and usability by other investigators. We propose to link the multiple data elements from the same patients and connect different repositories of shared data, to enhance its future use in ML, artificial intelligence and deep learning applications.